Bioinformatics, Statistical and Methodological Core

The primary goal of the Bioinformatics, Statistical, and Methodological Core (BSMC) at the Florida-California Cancer Research, Education & Engagement (CaRE2) Health Center is to provide the data management, data cleaning, data storage, and data release to public databases for all information generated by our Center. In addition, it will provide bioinformatics, statistical and methodological support for all the cancer research projects proposed, as well as future projects that will build upon them and will be disseminated to all CaRE2 Center members and the scientific community at large in a timely fashion. We will reach these goals through three aims: First, we will provide bioinformatics, statistical, and methodological support. This first aim is to establish the job scheduling and interfaces to meet the needs of all CaRE2 Health Center investigators. We will support bioinformatics and statistical issues across the projects and cores. Bioinformatics support will include in-depth quality control and assessment of all high-throughput sequencing data from multiple platforms and facilitate access to publicly available datasets. Statistical and methodological support will consist of all data management, from collecting data to state-of-the-art data analysis and interpretation as well as abstract, manuscript, and grant preparation. The second aim will be enhancing and maintaining a federated data repository resource that enables the interaction of CaRE2 members. This second aim will ensure that all data are of high quality and disseminated promptly to all CaRE2 Center members and the scientific community. In the third aim, we will provide bioinformatics, statistical, and methodological educational opportunities to the CaRE2 Center. This third aim focuses on developing online educational materials that BSMC's members and guest experts will present through the core events, such as seminar series and interactive lectures among all CaRE2 Center members.